Epac1 as a novel therapeutic target for diabetic retinopathy

PROJECT SUMMARY
This is an equipment supplement request in response to PA-20-272 for a parental project R01EY033319, which
focuses on studying the roles of EPAC1 signaling the development of diabetic retinopathy (DR) and its potential
as a therapeutic target for DR. Each year, millions of Americans face vision loss related to diabetes. According to
the U.S. Centers for Disease Control and Prevention, more than 30 million Americans have diabetes, and a third
of diabetics aged 40 or over in the U.S. have DR and related diabetic eye diseases. While the pathogenic
mechanisms underpinning the development of DR appear multifactorial and remain incompletely understood,
abnormal neovascularization is a key contributing factor, supported by the fact that therapy with anti-VEGF
(vascular endothelial growth factor) drugs has become the gold standard treatment for DR and its complications
among other interventions. Whilst anti-VEGFs demonstrate modest clinical benefits, these drugs fail to fully
attenuate clinical progression or reverse damage to the retina and have to be administered frequently via invasive
intravitreal injections over many years. Thus, there is a pressing need to develop new therapeutic strategies to
improve the treatment of this devastating disease. A better understanding of the etiology and the molecular
mechanism of DR, as well as the development of novel mechanism-based therapeutics, will address a major
unmet medical need. This study combines genetic and pharmacological approaches to determine the functions
and mechanisms of Epac1-mediated pathogenic neovascularization and vascular dysfunction during DR
development. Successful completion of our proposed studies will not only provide new mechanistic insights into
understanding cAMP/Epac1-mediated vascular remodeling but also will lead to the discovery of a new class of
in vivo pharmacological agents that can be used as lead compounds for developing medications targeting DR
and other vascular proliferative diseases. For this specific supplement, we are requesting a gel-documentation
system to replace a broken system that has been a key piece of instrument necessary for our proposed studies.

Public health relevance
ROJECT NARRATIVE The objective of this study is to elucidate the role of Epac1 in diabetic retinopathy, the leading cause of blindness in adults, and to investigate the potential of Epac specific inhibitors as novel therapeutics for diabetic retinopathy.